The Expedit-Isotopomeric CrossLinking Mass Spectrometry (Expedit-ICLMS) technology for mapping global and dynamic protein-protein interaction networks

SUMMARY
This project seeks to develop new technology to enable global mapping of protein-protein interactions (PPIs)
in a condition-specific, timely and affordable manner, by individual researchers interested in specific biological
systems. Successful development of this technology is expected to have a transformative effect on all fields
of biomedical research, directly addressing the purpose of the Focused Technology Research and
Development R01 FOA (PAR-19-253). Global PPI networks are not only the most important resources for
understanding the molecular mechanisms underlying normal and aberrant biological processes, but also the
bases for understanding genetic interaction networks, constructing gene regulatory networks, and quantitative
modeling of biological processes. Current technologies for mapping global PPI networks are labor intensive,
time consuming, costly, plagued by false positives/negatives, and do not provide a way for individual
researchers to efficiently map global PPI networks for particular biological systems. The proposed technology
development is targeted to solve the two most important challenges facing crosslinking-mass spectrometry
(CLMS)-based global PPI mapping studies: 1) the complexity of peptide mixtures derived from crosslinking
samples with a large number of proteins and a large dynamic range of abundances, and 2) efficient and
confident identification of crosslinked peptides by whole proteome database searches. We seek to overcome
these challenges by developing a novel crosslinked peptide enrichment strategy, called Expedit, and
combining it with the powerful capabilities of ICL crosslinkers, a new class of MS-cleavable, isotopomeric, bi-
functional crosslinkers for crosslinked peptide identification. Unique features of ICLs permit 1) efficient
determination of individual peptide masses in each crosslink from MS2 spectra, and 2) identification of
crosslinked peptides by whole proteome database searching using a single MS2 spectrum per crosslinked
peptide. The combination of Expedit with ICLMS is expected to address the major limitations of current CLMS
approaches to enable routine large scale PPI studies for the first time.
In the Aims, we will first synthesize novel Expedit reagents and evaluate their effectiveness for
crosslinked peptide enrichment using increasingly complex mixtures. Once optimized, we will integrate Expedit
with ICLMS and evaluate the effectiveness of the technology for building global PPI networks in yeast. We will
evaluate the method in terms of the quantity and reproducibility of identified crosslinks/PPIs, the abundances
of the identified proteins, their localization, affinities and complex membership (if available). We will compare
our PPI networks to previously described yeast PPI networks. The effectiveness of the technology for
crosslinked peptide identification will be evaluated by comparing it to state-of-the-art CLMS-based
approaches. If successful, this project would provide a general and robust method for studying global PPIs
and their dynamics that can be applied to any organism for which a sequenced genome is available.

Public health relevance
Narrative Proteins interact with one another in networks to control information flow through biological systems, and alterations in these interaction networks underlie all diseases. This proposal seeks to develop transformative technology that will enable routine and detailed analysis of global protein-protein interaction (PPIs) networks in any biological system for which a sequenced genome is available. If successful, this capability is expected to provide insights into the molecular basis for cell function in health and disease, targets for therapeutic interventions, enable diagnostics, and improved ability to harness organisms for biotechnology.